TB-RICC 3.0

Abstract: TB-RICC 3.0 is designed to support the production of the highest quality observational and interventional research on tuberculosis (TB) and TB-HIV. To accomplish this goal, TB-RICC 3.0 will: i) collaborate with RePORT Country-Network Data Centers and Biorepositories to ensure that common data elements (CDE) of the Common Protocol and Specimen Tracking are accessible through the Global Data Template; ii) organize and/or strengthen select sites to participate in diagnostic studies and clinical trials; and iii) support the RePORT Country-Networks to ensure further development of TB diagnostic laboratories, TB-RICC 3.0 specialized laboratories, and biorepositories.

Public health relevance
PUBLIC HEALTH RELEVANCE: New tools are necessary for tuberculosis control. The Regional Prospective Observational Research on tuberculosis (RePORT) coordinating center (TB-RICC 3.0) will discover predictors of the development of TB and poor treatment outcomes and show that they are applicable across three continents. TB-RICC 3.0 will further support the development of a network of sites to study promising new diagnostics, vaccines, and drugs.